Development and evaluation of an avatar-guided mobile health intervention for emerging adults with alcohol misuse and suicidality

ABSTRACT
The proposed K99/R00 award aims to guide the applicant to research independence, specifically in mobile health
(mHealth) interventions for emerging adults with alcohol misuse and comorbid conditions. Emerging adults have
the highest rates of alcohol use disorders, suicidal ideation, and suicide attempts compared to any other age group.
These problems are highly comorbid, with alcohol intoxication serving as a risk factor for suicidality. However,
utilization of outpatient treatment services for alcohol or mental health is extremely low in this population, even
following emergency department (ED) visits for either problem. Emerging adults are likely to be responsive to
mHealth interventions, and mHealth is well-suited to the ED. mHealth can address an urgent public health need by
bridging the gap between discharge and access to outpatient care and by supporting emerging adults who do not
access outpatient care. This study seeks to design an evidence-informed interactive, avatar-guided mHealth
intervention to provide ongoing education, skills practice, mood and behavior monitoring, and personalized
feedback to reduce alcohol misuse and suicidality. This mHealth platform will be developed based on a review of
commercial suicidality and alcohol mHealth apps, in-person integrated interventions, and an existing avatar-based
mHealth platform, developed by co-mentor Easton. The study aims to: 1) seek feedback on the proposed mHealth
intervention avatar, content, and features from a national youth advisory board, consumers (e.g., emerging adults
with alcohol misuse and suicidality; n=25), clinical experts in emerging adult alcohol and suicidality treatment
(n=10) and ED staff (n=10) creating an alpha version of the intervention; 2) test [usability] of the alpha version and
[feasibility of research protocols] in an open pilot trial with (n=20) emerging adults, to inform a beta version, and 3)
evaluate [acceptability and feasibility] in a randomized controlled [feasibility] trial comparing the beta version [of the
avatar-guided mHealth intervention + standard ED care; n=30)] to an active control, a commercial suicide
prevention app (MY3 [+ standard ED care; n=30). Secondary aims of the RCT are to test for safety and early
signals of efficacy on a range of alcohol, suicidal ideation, and outpatient care variables at 6-, 12-, and 24-weeks
post-randomization.] An exploratory aim is to examine within-person changes in same-day alcohol misuse and SI
severity between intervention groups via daily diary and ecological momentary assessment. The training and
career development plan includes courses, workshops, seminars, reading, and hands-on research in areas critical
to the PI’s independence: mHealth intervention development within interdisciplinary teams, integrated alcohol and
suicidality interventions for emerging adults, randomized controlled trials with fully-technology-based interventions,
and lagged sequential analysis with ecological data. The R00 projects will provide pilot data to support future fully-
powered R01 applications for [efficacy trials] of the avatar-guided mHealth intervention. The K99/R00 award will set
the foundation of the PI’s independent research career, specializing in mHealth interventions for alcohol misuse.

Public health relevance
PROJECT NARRATIVE Emerging adults have higher rates of binge drinking, thoughts of suicide, and suicide attempts than any other age group, but very low use of substance use treatment. This project seeks to develop a mobile health intervention guided by an avatar for emerging adults who visit the emergency department and who binge drink and experience thoughts of suicide. Because emerging adults prefer mobile health and self-guided interventions and such technology is widely accessible, the proposed mobile health intervention could offer significant public health benefit in reducing alcohol use disorders and suicidal thoughts in emerging adults.